Development Core

Development Core Project Summary
Fostering new research and supporting the development of early career scientists is the primary mission of the
Development Core (DC). Key features of the Development Core include its weekly seminar series; an annual
signature event to catalyze research at the intersection of demography, data innovation, and population
disparities; planned and specific activities directed by chairs within each primary research area; a seed grant
program for early career population scientists and high-risk, high-reward population dynamics research
involving multiple investigators; and a summer grant writing workshop. The Development Core centers,
coordinates, and catalyzes scientific innovations in two ways: first, by leveraging services and resources from
other cores to create an interlocking system of support for intellectual interaction, interdisciplinary collaboration,
new and innovative research initiatives, and the successful and intensive mentoring and professionalization of
early career affiliates; and two, by providing significant seed grant resources and combined with intensive
feedback for all grant proposals from inception to submission and resubmission. Development Core resources
are prioritized for population scientists at UW and external affiliates based at research institutions not
supported by a population research infrastructure grant. The cross-core linkages, added seed grant resources,
and internal and external affiliate access, will be explained in the following description of the Development
Core's services, resources, and activities.